Core A - Administrative Core

Project Summary
The administrative core will provide a management plan to coordinate the whole SYBIL consortium by 1)
establishing an organizational structure centered on an Executive Committee responsible for monitoring overall
program progress and making decisions on staffing plans, allocation of resources, core usage and other
policies; 2) coordinating bi-weekly conference calls and organizing site visits between the project and core
leads, selected key personnel, the Scientific Advisory Group and NIAID; 3) assisting the investigators of this
consortium in reagents and data sharing, manuscript preparation, public release of data and submission of
semi-annual and annual progress reports to NIAID; and 4) providing training opportunities in systems biology
for the infectious disease scientist. The Core Director has expertise in the coordination of program projects and
big consortiums, as he is the Director of one of the NIAID Centers of Excellence for Influenza Research and
Response (CEIRR). Moreover, he has been successfully coordinating the previous U19 consortium,
“FluOMICS, The Next Generation.” The Core Co-Director is in charge of the training program to be
implemented in years 2 to 5 and he has past experience in organizing training for students in systems biology
approaches.